8th Global Symposium on Ketogenic Therapies

PROJECT SUMMARY
The ketogenic diet (KD) is an established medical therapy for drug-resistant epilepsy, and since its origins in
1921 has steadily grown in clinical importance and worldwide implementation. Moreover, the expanding research
into the scientific underpinnings of this metabolism-based treatment have highlighted numerous novel
mechanisms. Moreover, there is mounting experimental evidence for potential disease-modifying and
neuroprotective properties of metabolic substrates such as ketone bodies and fatty acids, such that preclinical
and clinical investigators have been exploring broader uses of the KD and its variants in diverse neurological
(and even mental health) conditions such as malignant brain cancer, autism spectrum disorder, Alzheimer's
disease, and bipolar disorder. Despite proven clinical efficacy and relative affordability compared to anti-seizure
medications, large regions of the world still do not and cannot broadly offer KD therapies to eligible patients.
Centers often have inadequate resources, as well as a lack of appropriately trained physicians and/or dietitians.
Furthermore, the latest research findings may not be well disseminated, and a lack of standardized protocols
and management strategies present additional barriers. Without adequate support or proper education, patients
may not consider this treatment due to its traditional restrictiveness and myths surrounding its use. Regular
regional and international meetings are needed where scientists, physicians, dietitians, nurses, social workers
and trainees at all levels can meet and discuss and share protocols, research innovations, clinical experience
and establish new collaborations in the growing KD field. The 8th Global Symposium on Ketogenic Therapies (to
be held September 17-21, 2023 in San Diego, California) is the latest in a successful and evolving biennial
conference series first launched in 2008 with support from a NIH R13 conference grant. There has been an
enduring collaborative spirit with a common purpose that has now matured into a new professional society called
the International Neurological Ketogenic Society or INKS. The 8th Global Symposium represents another leap
forward: the focus remains on promoting collaborative interactions among clinical and basic scientists
and trainees and disseminating the latest research to the community and beyond, and a strong emphasis
will be placed on standardizing and enhancing international dissemination and implementation – all of this
in the spirit of equity, diversity and inclusion. Moreover, this will be the first congress in the biennial series
organized in conjunction with two aligned organizations, the Glucose Transporter Deficiency 1 (GLUT1)
Foundation and the International Society of Neurogastronomy (ISN). The KD is the treatment of choice for the
GLUT1 deficiency syndrome, and ISN's focus on the science and practice of flavor perception represents an
often-neglected aspect of diet and nutrition that is central to compliance and success of dietary treatments. These
symposia will remain the definitive venue for progress in and advocacy for metabolism-based therapies for
neurological disorders.

Public health relevance
PROJECT NARRATIVE A high-fat ketogenic diet can arrest epileptic seizures even when anti-seizure medications prove ineffective. The Eighth Global Symposium on Ketogenic Therapies marks the 15th anniversary of the first NIH-funded global symposium on dietary therapies held in 2008 and leverages the continuing growth and successes of this biennial conference series. Professional meetings of this type are necessary to advance the science and practice of ketogenic and related therapies across the globe, and importantly broaden collaborations, expand the clinical and basic-translational science involving metabolism-based treatments, and pave the way for future generations of professionals.